The effectiveness, cost-effectiveness, and budget impact of interventions to improve the delivery of cervical cancer screening in Puerto Rico.

PROJECT SUMMARY
Cervical cancer incidence is increasing dramatically (2.5% per year) in Puerto Rico (PR), with increased
occurrence of regional (1.7% per year) and distant (4.7% per year) stage cancer, which reflects a real increase
and indicates missed screening opportunities. Unfortunately, 80% of cervical cancer cases diagnosed in PR
occur among low-income women covered by Medicaid or Medicare, who also have a 70% greater likelihood of
being diagnosed with cervical cancer. Cervical cancer screening uptake continues to decline in PR, particularly
among low-income Medicaid enrollees, mainly seen by government clinics. Barriers to cervical cancer
screening in PR are mainly due to personal (lack of transportation, obesity-related embarrassment) and
environmental (repeated disaster events that hampered screening uptake and made recovery slow) factors.
The absence of evidence on the effectiveness, cost-effectiveness, and budget impact of patient navigators has
limited its adoption among government clinics in this US territory. Multicomponent interventions that can
address common screening barriers and improve screening participation in clinic-based settings or avert the
need for a clinical-based visit could help improve screening uptake and follow-up care. Our preliminary work
suggests the feasibility and acceptability of HPV self-sampling in PR. We now propose a hybrid type 1
effectiveness-implementation study using a four-arm multi-site randomized controlled trial (RCT) conducted
within government OBGYN clinics in PR. We will assess the effectiveness of patient reminders plus patient
navigation and HPV self-collection (individually and in combination) compared to patient reminders alone in
increasing cervical cancer screening, timely colposcopy, and cervical precancer treatment (Aim 1). The
secondary aim will evaluate key implementation outcomes, including patient and provider receptivity, reach,
level of implementation and fidelity, and sustainment intentions. We will then develop an open-cohort
microsimulation model to evaluate the population impact, cost-effectiveness, and budget impact of alternative
strategies (Aim 2) to inform their potential applicability at delivery organization, community, and territory levels.
This study will provide much-needed knowledge that is necessary to successfully facilitate the adoption and
sustained integration of optimal strategies that will improve cervical cancer screening participation and reduce
magnifying disparities in Puerto Rico.

Public health relevance
Project Narrative Cervical cancer incidence has increased among Puerto Rican women in recent years. This study will evaluate the impact of patient reminders, patient navigators, and self-collection on cervical cancer screening and follow- up care among Puerto Rican women. To inform the future broad-scale implementation of the effective approaches, we will also identify factors influencing the use of these strategies and determine their cost- effectiveness and budget impact.